Biomedical Informatics Section (BIS)

We interact with NIDA/IRP investigators to develop biomedical informatics applications and solutions that can access, manage, disseminate, and analyze large quantities of high-quality data. We develop, research, and/or apply computational tools to assist in the acquisition and analysis of biological, medical behavioral or health data, within a specific time frame determined to be appropriate by the NIDA/IRP. We help facilitate new system initiatives and changes to existing systems to meet legislative, regulatory, and departmental requirements within the specific time frames designated by each requirement. We conduct routine system analysis of automatic data processing resources and techniques of existing projects. We recommend, as needed, the implementation of new technologies that are efficient and timely.

We provide technical and professional support to help integrate computer systems, design or acquire computer programs, configure and support networks and streamline automated data processing within the NIDA/IRP's specified timeframe. We also integrate scientific data systems with network services and cybersecurity services to foster safe and secure NIDA/IRP laboratory collaboration and for collaboration with extramural entities, when possible integrate scientific data systems with one another and ensure design for interoperable data.

We automate various aspects of clinical and non-clinical programs at the NIDA/IRP. These include but are not limited to functions related to research participant recruiting, pharmacy, nurses, physicians, and other investigators including those at the Johns Hopkins University School of Medicine and University of Maryland.